Novel macrophage mediated signals regulate the immunoregulatory environment of the neonatal liver

Project Summary
The balance between regulatory and immunogenic immune responses is critical for liver homeostasis during
perinatal life because dysregulation of either can lead to chronic viral infection from sustained immune
suppression (as in chronic neonatal hepatitis B) or, to neonatal cirrhosis from unmitigated inflammation (as in
biliary atresia). It is therefore essential to understand the mechanisms that maintain the delicate balance between
regulatory immune responses and immunity in the perinatal liver as devastating sequelae of either too much
immune suppression, in the case of chronic neonatal hepatitis B, or too much immunity, in the case of biliary
atresia, leads to significant morbidity. In this proposal, we will investigate the role of the scavenger receptor
MARCO in maintaining this crucial balance between regulation and immunity in the perinatal liver. Scavenger
receptors are cell surface receptors found on phagocytic immune cells, and are important mediators of immune
homeostasis, inflammation, and tolerance. We have identified an important role for the class A scavenger
receptor MARCO expressed on macrophages in tuning immunoregulatory responses and inflammation in the
perinatal liver. Our preliminary data indicates that MARCO is highly expressed on mouse and human liver
macrophages, restricts anti-inflammatory myeloid cells, and worsens outcomes in a mouse model of perinatal
liver inflammation. Our data also support the idea that MARCO restricts anti-inflammatory functions of
macrophages by limiting responsiveness to the potent anti-inflammatory cytokine interleukin-10 (IL-10). We
therefore hypothesize that MARCO restricts regulatory/anti-inflammatory immune responses by inhibiting
responsiveness to IL-10. To address this hypothesis, we will use novel tools that involve technically challenging
portal vein injections of a model antigen to quantify endogenous antigen-specific immune responses in neonatal
liver and a CRISPR-Cas9 based method to ablate MARCO in primary human macrophages. Along with our
established model of perinatal liver inflammation, we will use these tools to address the following Specific Aims:
Aim 1: Determine whether MARCO restricts immunoregulatory responses by directly inhibiting the IL-10
receptor; Aim 2: Determine whether MARCO inhibits antigen-specific regulatory responses in the liver; Aim 3:
Test whether MARCO limits resolution of perinatal liver inflammation by inhibiting anti-inflammatory monocytes.
Completion of the proposed Aims will define the role of MARCO in perinatal hepatic immune function and will
yield important insights into how macrophage-mediated immune signals maintain the balance between immune
regulation and immunity in the developing liver. Understanding these signals is critical to elucidating the
pathogenesis of highly morbid liver diseases in pediatric patients and is the next important step for being able to
design potential therapies.

Public health relevance
Project Narrative Understanding the mechanisms that maintain the balance between immune regulation and immunity in the perinatal liver will yield critical insights into how immune dysregulation contributes to life-threatening pediatric liver disease. This proposal investigates the role of the scavenger receptor MARCO in maintaining this balance in the perinatal liver through its modulation of anti-inflammatory cytokine responses. The insights gained from this study will elucidate the mechanisms by which immune homeostasis in the perinatal liver is maintained, providing the necessary foundation for designing targetable therapies to mitigate highly morbid liver diseases that occur in infants and children.